Administration Core

The Administrative Core will provide comprehensive administrative support for all Projects/Cores, as well as to fulfill reporting requirements to DAIDS and provide ongoing assessment of the programs progress. Specific areas of responsibility will include: 1. Provision of biostatistical support;2. supportive data management, information exchange;3. coordination of communication among program investigators;5. addressing intellectual property issues;6. support of the external scientific advisory board;and 7. travel coordination and support.